NEW CHEMICAL PROBES ENABLE MASS SPECTROMETRY-BASED FOOTPRINTING OF HUMAN PROTEIN STRUCTURE IN LIPID MEMBRANES AND CELLS

PROJECT SUMMARY
Not applicable per solicitation.

Public health relevance
Project Narrative The requested equipment, a micro/nanoflow high performance liquid chromatograph, is a replacement for a vital component on our analysis platform. The platform enables reading footprints of membrane proteins, which are the communication, transport, and interaction centers for most of the drugs currently in use. The footprints reflect changes in structure and bring insight on how membrane proteins function.